Impaired sensory filtering as a mechanism of Parkinson's disease

PROJECT SUMMARY
Conventional models of Parkinson’s disease (PD) dysfunction do not account for sensory feedback, which is
both clearly represented in the basal ganglia and clearly impaired in PD. Despite the critical importance of this
feedback to normal movement, the contribution of impaired sensory processing to PD pathophysiology is
unknown. Our long-term goal is to clarify the role of sensory feedback in the production of pathological motor
commands in PD. This research could help reveal the neural basis of both PD pathology and its treatment,
leading to more efficient clinical practices, driving the development of novel therapeutic technologies, and helping
to alleviate the enormous burdens of PD on patients and providers.
In healthy people, the motor system will automatically ignore sensory feedback that is not directly relevant to
the current behavioral goal. In this proposal, we seek to determine whether the basal ganglia participate in this
goal-directed sensory filtering, and whether this process is impaired in PD. This phenomenon could potentially
provide a framework to explain PD motor symptoms with a single underlying cause: normal sensory feedback is
not filtered appropriately, which reduces the ability of the motor system to produce normal commands.
Underdamped sensory feedback could produce excessive transcortical reflexes in rigidity, corrupt the brain’s
internal models and interfere with movement planning in bradykinesia, and even produce tremor via stochastic
resonance (a phenomenon common in nonlinear neural systems in which a sub-threshold oscillation is amplified
by noise).
Whether or not our specific hypotheses are supported, the experimental paradigms of this study will
generate unparalleled data and insights into sensorimotor integration in the human brain. If our hypotheses are
correct, however, we will further provide a framework for an unprecedented mechanistic model of PD symptom
generation and a roadmap towards improved treatment.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease (PD) is highly prevalent and associated with significant disability and mortality, but the neural mechanisms underlying its pathophysiology are still unclear. In the long-term, we seek to clarify the contribution of sensory feedback to the generation of pathological motor outputs in PD. A more complete model of both motor and sensory dysfunction in PD will enhance our fundamental understanding of this disease and help accelerate the pace of innovation in its treatment.